REGULATION OF GAMETE USE AND NEURAL PATHWAYS IN REPRODUCTION

PROJECT SUMMARY
Sexual reproduction requires precise orchestration of expression of myriad genes in males and
females. These genes mediate interactions between the sexes at molecular, cellular, neural and whole-
organism levels, including the differential fertility success of sperm from two competing males that mate to a
single female. In the current funding period, we used the tractable Drosophila model system to dissect the role
of genes expressed in octopaminergic neurons in differential sperm use by a multiply-mated female. In this
renewal application, we propose as Aim 1 a set of experiments that identify genes and quantify their
effects on mating plug ejection, a proximal phenotype with a key role in sperm competition outcomes.
Mating plug ejection timing allows females to exert control over paternity of their future offspring. Early ejection
of a mating plug disadvantages the male by decreasing the number of his sperm that can be used; conversely
longer retention of the plug gives the male a paternity advantage. Both males and females contribute to the
mating plug and its ejection. After completing a GWAS for female and male determinants of mating plug
ejection timing and validating the resulting genes, we will perform a grid cross to determine whether variation in
mating plug timing is mostly determined by genetic variation in the male, or the female, or an interaction
between the two. Follow-up perturbation of those genes will begin to unravel genetic pathways linking male
quality or its perception with mating plug ejection. In Aim 2, we will pursue the implications of our recent
discovery that mating induces differential exon or promoter use by a large suite of genes in the female
brain. Intriguingly, two of these genes, desat1 and foraging, act in mating discrimination or other reproductive-
relevant behaviors. Each strongly activates one of four alternative promoters in response to mating. We will
survey the transcriptome to quantify how variation in male factors drive post-mating differential transcript use,
how the latter varies across female genotypes, and how this regulation occurs. In Aim 3 we extend and
generalize models designed to quantify and predict outcomes of pairwise interactions. The classical
Bradley-Terry model, widely applied in predicting outcomes of sporting contests between teams that have not
yet competed, has a direct analogy in sperm competition “contests.” Assessing fit to models of this class will
test whether the males’ fitness can be rank-ordered, and whether those rank orders produce accurate outcome
predictions. We will extend these models to the outcomes of the experiments in Aims 1 and 2, and those
performed in this project over the years, using the results to assess the overall importance of male x female
interactions in each case. Many of the processes that we will study show high levels of evolutionary
conservation, implying that our results will expand our understanding of male x female interactions in
reproduction that may have relevance to cases of idiopathic human infertility that may involve genetic
incompatibility between the partners.

Public health relevance
PROJECT NARRATIVE Fertility requires many levels of interaction between males and females – at the level of gametes and their fates in the reproductive tract and at neural/behavioral levels – and their ultimate success varies dramatically with the genotype of the male and female involved. This variation affects the likelihood of a particular male siring offspring with a given female, due to interactions between male and female components that impact the handling of sperm within the female, and the regulation of genes in her brain. Our proposed studies with a tractable and sensitive model system will uncover the extent and mechanisms by which genetic variation can alter reproductive outcomes, and how these can be predicted analytically for given pairs of interacting animals.